PEGRHUMGDF FOR TREATMENT OF THROMBOCYTOPENIA IN PATIENTS W/ HIV

The hypothesis being tested is that thrombopoietic stimulation with Mpl ligands improves the effectiveness of platelet production sufficiently to normalize the megakaryocyte proliferation. This possibility was examined primarily in HIV-infected thrombocytopenic chimpanzees by administering the Mpl ligand pegylated recombinant human megakaryocyte growth and development factor (PEG-rHuMGDF). The peripheral platelet counts increased 10-fold within 10 days without increasing viral loads or decreasing platelet antibody levels.